Precision Immunology Laboratory Shared Resource

Abstract/Project Summary
PRECISION IMMUNOLOGY LABORATORY SHARED RESOURCE (PIL)
The Precision Immunology Laboratory Shared Resource (PIL) is a highly restructured PCC
Shared Resource designed to comprehensively study immune cell phenotype and function. The
mission of PIL is to characterize and understand anti-tumor immune responses, determine
mechanisms by which immune escape and evasion occur, and predict patient responses to
cancer immunotherapy, in support of Perlmutter Cancer Center (PCC) investigators. Under the
direction of world-recognized immune monitoring expert Dr. Pratip Chattopadhyay, formerly of
the NIH Vaccine Center, PIL offers a wide range of services for immune monitoring, including
high quality cell processing and immunoassays for PCC clinical trials, with rigorous quality
control and bioinformatics capabilities to interpret the results. PIL also provides a wide range of
flow cytometry services (including education) for basic, population and clinical researchers at
PCC, and applies cutting-edge technology for high parameter, single cell immune analysis, that
provides results that are robust, accessible, and interpretable by researchers and clinicians.
The Specific Aims of PIL are: Aim 1) To provide high-quality cell processing and immunoassays
for PCC clinical trials with vigorous quality control and bioinformatics capabilities; Aim 2) To
provide a wide range of flow cytometry services, including education; Aim 3) To develop and
apply cutting-edge technology for high parameter, single cell immune analysis providing robust
results no generally available elsewhere.